INSULIN INFUSION TEST AS DIAGNOSTIC TOOL IN INVESTIGATION OF HYPOGLYCEMIA

CDMAS USE ONLY. To determine the relative roles of reduced hepatic glucose output, increased glucose uptake in insulin sensitive tissues and counter-regulatory hormone responses in the genesis of hypoglycemia in patients with insulinoma.